Postdoctoral Training in Biomedical MRI and MRS

Summary / Abstract
This is an application for renewal of a highly successful, competitive and comprehensive institutional
postdoctoral training program in magnetic resonance imaging (MRI) and spectroscopy (MRS) that has been in
place at Vanderbilt University since 2003. The 30 preceptor faculty comprise an experienced and expert group
of research scientists engaged in the development and application of MR methods in several different
important research areas and across different scales. MR methods serve not only as the single most important
modality in diagnostic imaging but also provide crucial insights into biological processes and structure to
address fundamental questions in biomedical research. There are continuing advances in MR technology, but
there is a shortage and a critical need for appropriately trained scientists capable of fully exploiting the potential
of MR techniques. We have developed a comprehensive training program in biomedical MRI and MRS
designed for outstanding postdoctoral scientists from different backgrounds. Some have been exposed to
imaging and MR methods before, but others have had little previous significant experience in biomedical MRI
and MRS. Postdoctoral trainees from physics, chemistry, biology, engineering or medicine may receive
thorough and exemplary instruction in all of the cognate areas relevant to biomedical NMR in a coherent and
comprehensive program. In addition, trainees pursue research in MR methods and applications (mainly) in
neuroscience, radiology, cancer and metabolic disorders and are co-mentored by collaborators from relevant
clinical departments. Our program continues to evolve and in this renewal several notable enhancements are
described. The formal training includes an educational program, consisting of courses, seminars, and journal
clubs; a practical program, consisting of faculty-led tutorials and practical training; and a research program, in
which trainees are integrated into an active research program. These programs illustrate most major aspects of
the applications of MR methods in humans and animals. Trainees have access to outstanding facilities
including three research-dedicated human MR systems (2 at 3T and one 7T); animal MR systems at 4.7T, 7T,
9.4T and 15.2T; and other imaging modalities. Trainees are also mentored in the ethics and methods of
biomedical research, in rigor and reproducibility, as well as in grant writing and other important career skills.
Our previous trainees have been very successful in their careers after leaving our program. Of 50 trainees to
date, 20 are now faculty at major research universities, 12 continue as research fellows or research scientists
in medical centers, 3 work in MR-related industries, 5 are engaged in biomedical administration or government
positions, 2 are physicians, 6 are still in training, one died and and one is no longer able to work. The
programs, personnel, and facilities at Vanderbilt provide outstanding opportunities for training in biomedical
NMR of the highest caliber, and will ensure the remarkable insights into biology and disease made possible
with MRI and MRS will be realized.

Public health relevance
Project Narrative This application is for support of a comprehensive training program for postdoctoral trainees to become experts in different aspects of magnetic resonance imaging (MRI) and spectroscopy (MRS) to be able to contribute to their translational applications. MRI and MRS are very important methods for the non-invasive diagnosis of diseases and monitoring of treatment in clinical practice, and provide vital information for a wide range of other biomedical research applications. This program will address the shortage of suitably qualiﬁed postdoctoral scientists able to contribute to the further development of MR methods or to apply them effectively.